DAB486 IL2 USED IN PATIENTS WITH SELECTED IL2R EXPRESSING MALIGNANCIES

This is an open label study to investigate the safety, tolerability, pharmacokinetics and possible efficacy of DAB486IL2 in 18 patients with refractory leukemia/lymphoma.